Core C - Measurement and Methods in ADRD and Racial Disparities Research

The primary goals of the Measurement and Methods Core are first to advance the science of measuring ADRD symptoms and diagnosis, stages or severity of dementia, and cognitive impairment in CMS and other databases; second to advance the science of identifying patient, and to some extent provider demographic measures in these data; and third to identify and link likely cohabitating caregivers in these data. The proposed Core C workplan progresses from applying current best practices in year 1 to the continuing development of expert-informed state- of-the-art measurement improvements in subsequent years. These methods and measures are developed in Core C, and then applied to the NBER’s CMS databases in Core B. In collaboration with Core A, we also plan a series of meetings and workshops, first to insert practical ADRD care experience including a community advisory panel, into the ADRD measurement work of Core C and the empirical analytics of the research projects, and second to share the methods and measurement innovations of Core C with the wider research community.

Public health relevance
Alzheimer's disease and related dementias (ADRD) are progressive neurocognitive disorders with an enormous and varying burden on patients, their families, the healthcare delivery systems, and the entire society. This core will help to address the challenges of ADRD identification and measurement in existing data, and the deficiencies in existing analytic methods across demographic groups, particularly for identifying beneficiaries with mild cognitive impairment (MCI), the stage at which new medications appear most promising,